Mechanism of F. Nucleatum in Intrauterine Infection

Project Summary There have been no changes from the original submission.

Public health relevance
Project Narrative There have been no changes from the original submission.